Identifying cortical and brainstem regions contributing to partial hand function post- stroke

PROJECT SUMMARY/ABSTRACT
The majority of individuals with hemiparetic ischemic stroke experience motor impairment in their upper
extremity, specifically affecting the wrist and fingers. Wrist/finger weakness in these individuals is greater for
extensors than flexors, causing a much higher difficulty in hand opening than closing. This problem is even more
pronounced in severely impaired individuals who experience involuntary hand closure when trying hard to open
it. Previous brain imaging studies have reported increased neural activity in motor, premotor and supplementary
motor areas of both hemispheres, especially contralesional hemisphere, during hand movement in individual
with stroke. Some have also reported this increased activity in contralesional motor cortices to be correlated with
improved hand function post stroke. Moreover, our previous work in altered sensorimotor pathways post stroke,
with the use of advanced MRI techniques, demonstrated an increased reliance on ipsilaterally projecting cortico-
bulbo-spinal pathways in individuals with hemiparetic stroke. However, it is still unclear which cortical motor
areas and motor pathways facilitate the preserved ability for wrist/fingers flexion and restrain the wrist/fingers
extension after damage to the corticospinal pathway in stroke. Although it is unexplored in humans, animal
studies of brainstem ipsilaterally projecting pathways have reported that the stimulation of reticulospinal and
vestibulospinal tracts’ nuclei in brainstem would cause flexion at the ipsilateral limb; in other words, ipsilaterally
projecting cortico-bulbo-spinal tracts tend to be flexion-biased. Given this information, we hypothesize that
relatively preserved ability to flex wrist/fingers and limitation in ability to extend after stroke is the result of a
greater reliance on contralesional motor cortices and brainstem motor nuclei of the ipsilaterally projecting cortico-
bulbo-spinal pathways. The overall aim of this proposal, therefore, is to identify the activity in motor cortices (Aim
1) and ipsilaterally projecting motor pathways’ nuclei in brainstem (Aim 2) during separate hand opening and
closing tasks in individuals with chronic hemiparetic ischemic stroke, using novel and high-resolution 7Tesla
functional MRI (7T fMRI) methodology. Moreover, we hypothesize that higher reliance on contralesional motor
cortices and their ipsilaterally projecting motor pathways’ nuclei in the brainstem is led to an increased functional
connectivity between these motor centers in individuals with stroke (it will be tested in Aim 3). Successful
completion of these specific aims will help elucidate the brain regions that facilitate partial hand function post
stroke, and pave the way for the development of more effective and targeted therapeutic interventions for these
individuals through utilizing the remaining brain regions and pathways post stroke.

Public health relevance
PROJECT NARRATIVE The majority of individuals who have experienced hemiparetic stroke suffer from wrist/finger weakness, which is greater for extensors than flexors, causing a much higher difficulty in hand opening than closing in these individuals. This research aims to determine the cortical and brainstem regions which facilitate the hand closing but not opening after stroke with the use of high-resolution and novel magnetic resonance imaging methods. By gaining a deeper understanding of the neuroplastic changes in individuals with stroke, this research will pave the way for the development of more effective neurotherapeutic interventions in chronic phase of stroke.